BD FACSymphony S6

SUMMARY/ABSTRACT
This proposal requests funds to purchase a BD FACSymphony S6 flow cytometric sorter to be housed in an
active and established core, the Flow Cytometry Core at the California National Primate Research Center
(CNPRC). The CNPRC is one of seven national designated primate research centers. Local, regional, and
national investigators pursue translational research at CNPRC that is relevant to immunology, infectious
disease, gene therapy and somatic cell genome editing, regenerative medicine and stem cell transplantation,
cardiovascular disease, cancer, and neurodevelopment. The instrument is requested to support >20 current
NIH-funded research projects from 6 Major Users and 11 Minor Users, as well as pending and future NIH-
funded research, that spans basic, translational, and even clinical research. These projects include studies of
therapeutic HIV vaccines, SIV pathogenesis, genome editing, retinal gene therapy, tissue-targeted AAV
vectors, and even a phase-1/2a human clinical trial of a next-generation COVID vaccine candidate, for which
mechanistic immunologic analysis will be performed at UC Davis. All these studies and indeed much of
modern biomedicine requires the ability to separately study functions of specific cell types, or even individual
cells. To perform such studies reproducibly and at an adequate quality level, furthermore, requires an
instrument that is consistently checked and maintained, and one that should be under service contract. The
BD FACSymphony S6 flow cytometric sorter will serve the increasing number of samples of our Users that are
currently stressing a >20-year-old FACSAria flow sorter. The FACSAria was purchased using institutional
funds and has been successfully maintained for an extraordinarily long serviceable lifetime, and was under
service contract continuously until BD no longer offered the contract. However, the age and wide use of the
older instrument impacts availability to the expanding NIH-funded research of our Major Users. Together,
these constraints are hampering the progress of NIH- funded projects in their laboratories as well as efforts of
their collaborators. The FACSymphony S6, with its greater selection of channels matched to those in our
analytic cytometers, better robustness, more consistent maintenance, and higher laser power, will significantly
advance our Major and Minor Users’ pursuits of novel mechanistic insights. We will integrate this instrument
into an existing CNPRC core facility, the Flow Cytometry Core, which is maintained by UC Davis and CNPRC
with significant infrastructure and oversight and advisory committees. The existing infrastructure will integrate
the operation, maintenance and management of the proposed instrument which will, in turn, stimulate new
research projects and innovations for many years.

Public health relevance
NARRATIVE The goal of this S10 shared-instrumentation grant is to obtain a BD FACSymphony S6 cell sorter to be placed in the Flow Cytometry Core of the California National Primate Research Center, where it will be dedicated primarily to use in translational, preclinical studies with nonhuman primates. This instrument will significantly benefit studies spanning research domains including immunology, infectious disease, gene therapy and somatic cell genome editing, regenerative medicine and stem cell transplantation, cardiovascular disease, cancer, and neurodevelopment—all to be addressed across the lifespan from pediatrics to geriatrics. The BD FACSymphony S6 will allow investigators to make observations at the single-cell level using samples from nonhuman primates, leading to new mechanistic understanding and eventually improved medical care.